Sleep duration Polygenic Risk Score: Association with cognition and brain measures

PROJECT SUMMARY/ABSTRACT
Sleep is a vital indicator of overall health and well-being, and serves many functions including essential roles
underlying cognitive processing. Changes in sleep are common among cognitively healthy individuals and those
with neurodegenerations such as Alzheimer’s disease dementia (AD)[1-4]. Thus, sleep disturbances have been
characterized as significant risk factors for cognitive decline and incident AD[5-8]. More specifically, short sleep
duration has been linked to poor cognitive performance and greater cortical β-amyloid (Aβ) burden, a precursor
to cognitive decline/ dementia[9-11]. Furthermore, genomic variability has been also reported as a significant
contributor to cognitive function and neurodegenerative disorders[12-16]. Polygenic Risk Scores (PRS) have been
improving over the last years to provide a better assessment of disease risk predictions[17].
PRSs developed to assess risk of AD were reported as significant predictors of cognition and different sleep
measures in elderly and in youth [18]. We recently showed preliminary data regarding the association between
sleep-based PRS (Sleep PRS) and cognition[19]. There is also reported evidence of an association between sleep
and brain structure[20-22], however, the majority of studies examine individual brain measures. Despite work
exploring the association between sleep and cognition, research on the link among sleep, sleep genetics and
cognition in cognitively healthy adults across the age range remains sparse. The current proposal aims to
investigate the association between a Sleep PRS, summarizing the genetic contribution to sleep duration[23-26],
with cognition, and the role of brain measures to this association. The analytical sample will consist of ~1900
cognitively healthy adults (20-80 y.o.) drawn from two cohorts; the Reference Abilities Neural Networks/Cognitive
Reserve (RANN/CR), and the Washington Heights-Inwood Columbia Aging Project (WHICAP). The specific aims
are to: a) characterize the association between Sleep PRS and cognition both cross-sectionally and
longitudinally, b) identify how brain measures might mediate these associations, and c) expand the work by
creating a Cognitive PRS, evaluating it in a similar manner, and examining overlap with the Sleep PRS.
This K99/R00 application presents a program that will support the applicant on a path towards becoming an
independent investigator focused on characterizing the association between genetics and cognition, while
examining the role of brain measures in this association. The activities in this application are set in a resource-
rich environment that will provide the applicant with new skills, deepening, and strengthen her expertise in: 1)
genetics, 2) neuroimaging, 3) cross-sectional and longitudinal analyses of cognitive behavior data, and 4) the
responsible conduct of research. The combination of the environment at Columbia University, training plan, and
mentorship team will not only provide the candidate with a spectrum of new methods and skills that will establish
her as an independent research scientist, but will also produce a body of knowledge that will clarify how sleep
genetics are associated with cognition in cognitively healthy participants across the adult age-range.

Public health relevance
PROJECT NARRATIVE Assessing the genetic contributions underlying the association between sleep and cognitive status (healthy aging/ Mild Cognitive Impairment/ Alzheimer’s disease) will lead to a better understanding of the neurobiological pathways driving sleep and cognition. Using bio-behavioral methods and advanced statistical modeling, the proposed research aims to characterize the association between cognitive performance and a Polygenic Risk Score based on sleep, identify how brain structural measures may mediate the association, and expand the work by creating and evaluating a Cognitive Polygenic Risk Score. The results from this research will provide mechanistic insights about the contributions of sleep disturbance to cognitive dysfunction, genetic trait susceptibility, and possible translational and therapeutic benefit.